Examining neuronal resilience in a mouse model of sporadic ALS

Project Summary/Abstract
Following an injury to the brain, healthy neurons that are adjacent to the damaged area can sometimes take
over the functions performed by the impaired neurons. This process has been best studied after acute nerve
damage, but there is evidence that compensation by surviving neurons is also happening in the early stages of
neurodegenerative diseases. In amyotrophic lateral sclerosis (ALS), the fiber type grouping in muscle samples
taken from patients suggests that after an initial loss of connections between motor neurons (MNs) and muscles,
new nerves are able to reconnect to allow patients to maintain movement during the disease process. A second
observation made at the time of autopsy is that the vast majority of patients have an accumulation of a
mislocalized protein called TDP-43 in the surviving MNs. However, because these cells are inaccessible in early
disease stages, the molecular mechanisms for coping with disease processes in the MNs that send out new
connections to muscles are unknown. In order to determine the dynamic responses that could allow a
subpopulation of MNs to cope specifically with mislocalized TDP-43 and send out new axonal connections to
muscles to prevent paralysis, we developed a mouse model in which we can induce neuronal expression of
mislocalized human TDP-43, called rNLS8 mice. We then showed that rNLS8 mice have certain subsets of MNs
that are uniquely vulnerable to disease, and that surviving MNs can effectively take the place of these cells, even
late into the disease course.
In this study, we will now identify the populations of MNs responsible for the reinnervation and restoration of
function of vulnerable muscles after the initial TDP-43 triggered MN loss (Aim 1), using a combination of neuronal
tracing techniques, muscle physiology, and imaging at the neuromuscular junction. We will then look for the
upstream contribution of the brain's immune cells, microglia, to MN plasticity and the resultant circuit changes
(Aim 2) by pharmacologically eliminating microglia and selectively reintroducing microglial derived factors that
have been previously shown to influence neuronal function. Finally, molecular differences between MNs that
innervate the same muscle before and after TDP-43 triggered axonal dieback will be uncovered by RNA-
Sequencing and the top gene targets will be validated for their effect on motor function during ALS-like disease
in rNLS8 mice (Aim 3). Completion of these studies should provide valuable insights into the potential
mechanisms by which subsets of MNs can tolerate a build-up of cytoplasmic TDP-43. Moreover, understanding
the mechanisms of neuronal compensation could allow for the development of therapies aimed at supporting
surviving cells in order to extend their natural plasticity to slow disease and maintain function in patients.

Public health relevance
Project Narrative In the early stages of ALS, resistant motor neurons are able to compensate for the loss of their more vulnerable counterparts, allowing for continued, albeit temporary, muscle control in patients. Because these cells are inaccessible in patients during this time period, this study uses a mouse model of sporadic ALS to track the changes in and around resistant cells that allow for this compensation. Identifying the ways that these neurons can naturally cope with a disease-relevant pathological protein can allow us to design strategies to slow the disease progression by 1) conferring that resistance on more vulnerable cells, and 2) extending the timeline of this compensation.